Physician-Scientist Research and Medical Education (PRIME) Program

ABSTRACT
Racial and ethnic diversity in the biomedical research workforce produces higher quality science,
expands the national research agenda, and increases clinical trial participation among
underrepresented populations. Nevertheless, racial and ethnic diversity in the biomedical research
workforce remains low, and the United States Congress has cited the lack of diversity in the
biomedical research workforce as a serious concern. Diversity among physician-scientists is
particularly important. Because of their expertise in clinical medicine and scientific research,
physician-scientists play a valuable role in the biomedical research enterprise, and diversity among
physician-scientists is essential to generate impactful science. Although Increasing diversity is a
national imperative, evidence-based interventions remain elusive, and a lack of diversity in the
biomedical research enterprise persists. In 2020, despite comprising 13% and 19% of the U.S.
population, only 2% and 5% of NIH R01 grants were awarded to Black and Latinx scientists,
respectively. In order to meaningfully disrupt this lack of representation and advance the science of
workforce diversity, our group, the Promoting Diversity, Group Inclusion and Equity (ProDiGIE)
research lab will address three fundamental knowledge gaps. First, through an innovative positive-
deviance study design, we will identify evidence-based interventions to increase the racial and ethnic
diversity of trainees pursuing a career as a physician-scientist. Second, we will identify strategies to
promote and sustain physician-scientist professional identity formation among trainees
underrepresented in science. Third, we will identify interventions to foster the success of faculty in
academic medical centers, which receive over two-thirds of all NIH funding. The proposed research
program will comprehensively and systematically investigate interventions to promote diversity across
the physician-scientist career span from trainees to NIH-funded faculty.

Public health relevance
PROJECT NARRATIVE Diversity in the biomedical research workforce produces higher quality and more impactful science. Yet, there remains an unmet need to identify evidence-based interventions to improve the diversity of the biomedical research enterprise. The Promoting Diversity, Group Inclusion, and Equity (ProDiGIE) research program will comprehensively and systematically investigate and identify interventions to increase diversity across the physician-scientist career span from trainees to NIH-funded faculty.